NEONATAL RENAL VEIN THROMBOSIS

The objectives of this research will be (1) to determine the incidence of renal vein thrombosis (RVT) in infants whose births are complicated by maternal diabetes and/or the development of shock, polycythemia or asphyxia; (2) to determine the natural history of neonatal RVT; and (3) to assess outcome of asymptomatic RVT following supportive care alone versus therapy with heparin anticoagulation.